Enhanced Visibility, Engagement, and Reach of Lifestyle Change Interventions Project (EVER-LCI) and LCIRN Coordinating Center

PROJECT SUMMARY
This project aims to improve the health of all people living in rural communities throughout the United States by
improving the reach and engagement of evidence-based lifestyle change interventions (EB-LCIs). Component
A focuses on developing and evaluating novel marketing strategies to improve perceptions of EB-LCI feasibility
and motivation among rural populations. The activities within Component A include a landscape analysis to
identify innovative LCI approaches, discrete choice experiments to determine the best program features to
market to rural audiences, and a randomized controlled trial testing the use of bi-directional text messaging to
test optimized strategies to improve enrollment in EB-LCIs. The project will leverage the Mountain West Family
Healthy Weight Collaborative (MW-FHWC) and the CDC Prevention Research Center Network to engage
community members and organizations across diverse rural regions in the U.S. Component B establishes the
Lifestyle Change Implementation Research Network Coordinating Center (LCIRN-CC) to support and
coordinate the dissemination and implementation of EB-LCIs. The LCIRN-CC will leverage leading-edge
dissemination and implementation (D&I) science methods, community-engaged research processes, and will
leverage and innovate on the Mountain States Partnership for Community-Engaged Dissemination &
Implementation (MS-CEDI) Science Training Institute to include an implementation practitioner training track in
addition to the effective implementation researcher training track the institute developed and evaluated over
the last four years. The center will facilitate communication and collaboration across the Network, support
sustainable communities of practice, and build capacity for the next generation of EB-LCI D&I practitioners and
scientists. Additionally, the LCIRN-CC will provide technical assistance, mentorship, and resources to ensure
the successful implementation and sustainability of EB-LCIs across the Network. The ultimate goal of
Component A is to improve the reach and overall health of Americans living in rural areas. For Component B,
the ultimate goal is to contribute to generalizable implementation strategies and frameworks for EB-LCIs and
build researcher and practitioner capacity to contribute to sustainable improvements in population health.

Public health relevance
PROJECT NARRATIVE This proposal aims to improve the health of all people living in rural communities by enhancing the reach and engagement of evidence-based lifestyle change interventions. Component A will develop and evaluate novel marketing strategies to improve perceptions of intervention feasibility and motivation among rural populations, leveraging community engagement and innovative approaches such as bi-directional text messaging. Component B will establish the Lifestyle Change Implementation Research Network Coordinating Center to support and coordinate the dissemination and implementation of these interventions, integrating leading-edge methods, community-engaged research processes, and comprehensive capacity building and training programs to enhance sustainable public health outcomes.